A Modern Confocal Microscope to Maintain and Expand the Continuity of Basic Biology Research

Project Summary/Abstract
This proposal requests funds to purchase a laser scanning confocal microscope for a group of 13
investigators, from 4 departments and 2 academic divisions at the University of California at Santa Cruz.
10 of these investigators are NIH-funded. The proposed Leica Stellaris 8 (LS8) confocal microscope will replace
a 16-year-old Leica SP5 confocal microscope, which was purchased through a California Institute for
Regenerative Medicine grant mechanism and installed in 2008 and is at the end of its life. The LS8 is a flexible
and modular confocal laser scanning microscope for high-end fluorescence imaging. The LS8 was confirmed to
be an outstanding choice for our core facility through multiple demos as it is well suited for the research objectives
of our users. It is easy to use, provides a cost-effective solution to our research challenges and maintains and
expands the imaging capabilities of our local research community by introducing a White Light Laser for flexible
excitation, a broader detection spectrum compared to what we have now and the ability to do Fluorescence
Lifetime Imaging (FLIM). These capabilities make the instrument essential to the continuing the competitive,
high-standard NIH-funded biomedical research taking place at UCSC. The user group is funded by 7 NIH
institutes. These are the National Institute of General Medical Sciences (NIGMS), National Institute of
Neurological Disorders and Stroke (NINDS), the National Institute of Child Health (NICHD), the National Cancer
Institute (NCI), the National Institute of Allergy and Infectious Diseases (NIAID), the National Institute of Mental
Health (NIMH) and the National Human Genome Research Institute (NHGRI). The users seek to bring the power
of confocal microscopy to studies which include cancer, immunity, host-pathogen interactions,
neurodevelopment, stem cell fate specification, cell division, and neglected diseases. Additional currently non-
NIH funded projects are likely to receive NIH funding and are likely to nucleate NIH-funded inter and intramural
collaboration. Anticipated biomedical research faculty hires over the next decade will certainly require confocal
microscopy and demand is already projected to outpace availability, ensuring this microscope will be in high use.
This microscope system will become an integral part of UCSC's Life Sciences Microscopy Center core
facility (RRID:SCR_021135) in the heart of our Molecular, Cell and Developmental Biology Research Building.
This placement will allow convenient access for researchers studying basic biology in this building and to
researchers in our adjacent Chemistry and Biomedical Sciences buildings. The facility is open to all NIH-funded
investigators; thus, this equipment will enhance and sustain biomedical research on this campus, while providing
advanced training to our graduate students and postdoctoral research fellows, thereby helping to create the next
generation of biomedical investigators. Securing this instrument will have a significant impact on the contributions
to research and education made by UC Santa Cruz far beyond the 5-year post-award period.

Public health relevance
Narrative The proposed confocal microscope is essential for the continuation of biomedical research at UC Santa Cruz involving users currently funded by 7 NIH programs: NIGMS, NINDS, NICHD, NCI, NIAID, NIMH, NHGRI. These users require confocal microscopy to study host-pathogen interactions, stem-cell fate specification, neuronal development and circuit formation, human neural evolution, meiosis, mitosis and breast cancer. The Leica Stellaris 8 confocal microscope will provide our biomedical researchers the cutting-edge capabilities in sensitivity, signal isolation, FLIM, spectral precision and range needed to discover novel biological mechanisms and to provide the foundations for advancing improvements in human health and disease interventions.